Northwestern University CoFAR (NU-CoFAR) Clinical Research Center

Food allergy is a common disease with few treatment options, and although life-threatening reactions are very
rare, the lack of predictability of reaction severity contributes to a significant negative impact on quality of life.
Studies are needed to test new therapies, identify new targets through mechanistic research, and to advance
the understanding of key clinical parameters including severity, threshold, and prognosis for allergy resolution.
There is also a need to identify and rectify disparities in access to care and representation in research, an area
in which we have made significant contributions. As a first aim, a clinical research center – NUCoFAR- will be
established at Northwestern University using the expertise of investigators at the Lurie Children’s Hospital,
Feinberg School of Medicine, and the Center for Food Allergy and Asthma Research. These experts will recruit
children and adults with food allergy for observational or intervention studies, as well as pregnant women and
infants for prevention studies, and carry out human studies using best practices. Since food allergy exhibits the
characteristics of a complex genetic trait, it is imperative that research aiming to understand its etiology can
leverage large, heterogeneous patient populations, beyond those available at any single
institution. Consequently, the current understanding of this complex trait can be greatly advanced by
systematically combining data across multiple clinical research centers. A standard approach for doing this is
the creation of a data commons- a single, centralized resource that supports harmonized data aggregation and
access from disparate sources, in accordance with FAIR (Findable, Accessible, Interoperable, and Reusable)
principles. In a second aim, the CoFAR network will develop and populate a Food Allergy Data Commons
(FADC) that will facilitate network-wide data sharing and collaboration across numerous priority research
domains. We are partnering with leaders in the informatics field to advance this aim. NUCoFAR will work with
other CoFAR Clinical Research Centers to develop efficient data upload procedures to the FADC. This access
to standardized, structured data will allow the community of CoFAR researchers to answer critical research
questions around food allergy development, diagnosis, progression, severity, and potential for natural
tolerance. To advance the understanding of basic mechanisms of food allergy and oral tolerance, a third aim
will identify the role of T cell-B cell interactions resulting in tolerance from early allergen introduction. This
project will use biospecimens obtained by the CAN DO study, a multi-site clinical trial testing the impact of
introduction of eight allergens into the diet by nine months of age on the development of food allergy. The
contribution of T follicular helper (Tfh) cells and Type 2-marked memory B cells (MBC2) to the development of
allergy and tolerance to foods will be tested. By elucidating the immune mechanisms responsible for the
window of opportunity for oral tolerance development, these studies will identify novel pathways that could be
targeted therapeutically to help children and adults with established food allergy.

Public health relevance
Narrative Epidemiologic data published by our group estimate that 1 in 13 children and 1 in 10 adults have food allergies, which in turn impose substantial psychosocial and economic burden on affected patients and families. The NUCoFAR Clinical Research Center proposes to advance the prevention, management, treatment of food allergy by leveraging the complementary expertise of its MPIs and their experienced, multi-institutional research team. The proposed site-specific project aims to understand the basic mechanisms of food allergy and oral tolerance, while the proposed network-wide project will develop a CoFAR-wide data commons, which will harmonize and aggregate a wide variety of clinical and epidemiologic data for analysis and future network- wide collaboration.